Impact of neurovascular coupling on receptor-mediated transport of proteins into the brain

PROJECT SUMMARY
Transport of blood-borne signals into the brain must be tightly controlled to maintain neuronal health. Selective
transport across endothelial cells is achieved by receptor-mediated transcytosis, yet little is known about what
physiological signals stimulate this transport. Transcytosis is affected by alterations in membrane tension, such
as those caused by changes in blood vessel diameter. Hemodynamics are coupled to neural activity via
neurovascular coupling (NVC). While disruption of NVC is associated with neurodegeneration, the normal
physiological purpose of NVC is unknown. This proposal will test the hypothesis that NVC stimulates receptor-
mediated transport of proteins into the brain. To visualize movement of blood-borne proteins out of endothelial
cells, plasma proteins will be fluorescently labelled, and injected into mice with fluorescently-labelled endothelial
cells and visualized using two-photon microscopy. To understand how vascular dynamics can drive transport,
vasoconstriction and vasodilation will be pharmacologically induced. The contributions of neural activity to protein
uptake will be tested by sensory stimulation and by chemogenetically modulating the activity of genetically
defined neuronal populations. If neurovascular coupling gates protein uptake into the brain, this would provide a
novel form of temporally and spatially controllable body-brain communication. These experiments will contribute
to our fundamental knowledge of the signaling mechanisms controlling movement of blood-borne protein signals
from the body into the brain, which could inform the targeting of therapeutics for neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE Active transport of proteins into the brain must be tightly and dynamically controlled to maintain neuronal function and long-term health, yet little is known about how this transport is regulated. I will determine how neurovascular coupling influences receptor-mediated transport into the brain by tracking the movement of fluorescently labeled plasma proteins using two-photon imaging of the awake mouse brain. This research will contribute to fundamental knowledge of the signaling mechanisms connecting blood-borne protein signals from the body to a neuronal response in the brain, which could aid in the targeting of therapeutics for neurodegenerative diseases.